Patterns of Survivors' Recovery Trajectories in the ICECAP Trial (POST-ICECAP)

Project Summary: Many patients now survive out-of-hospital cardiac arrest (OHCA), however gaps in
knowledge about long-term outcomes result in a fragmented and underdeveloped continuum of care to achieve
recovery. Recovery is defined as significant improvement in functional and cognitive outcomes, and health-
related quality of life (HRQoL). OHCA Survivors with favorable recovery patterns may potentially go back to
work and/or social roles. Prior studies assessing recovery domains after OHCA are small, limited to single
centers, and short-term outcomes i.e., 1-3 months. Identifying individual patient patterns of recovery over
longer-term, and the ability to predict who will be likely to need more intensive support after discharge would
allow interventions to be targeted more efficiently. It is also crucial that we offer patients and their families the
best information available about a patient's prospects for continued recovery even in the absence of modifiable
intervention targets. This study will be among the first to focus on a new equitable science of OHCA
survivorship itself, seeking empirically derived targets for preserving or restoring recovery.
Our single-center pilot study has found that nearly one-third of the OHCA survivors had clinically important
differences between long-term (12 months) and short-term (3 months) functional outcomes with large between-
individual variability in recovery (i.e., improvement or worsening). We found that inpatient acute rehabilitation
was associated with better functional recovery patterns at 12 months compared to other dispositions, but Black
race and Hispanic/Latinx had worse recovery patterns than non-Hispanic Whites.
To fill this gap, we propose an ancillary study to the NINDS/NHLBI-funded ICECAP trial, conducted within the
60 sites of the NIH emergency care trials network, to describe recovery (functional outcome [primary],
Cognition, and HRQoL outcomes [secondary]) in a large, well-characterized, racially/ethnically diverse,
representative cohort of US OHCA patients. We will enroll n=1,000 who were screened for ICECAP and
survive to hospital discharge. The parent ICECAP trial includes a telephone follow-up visit at 1 month and an
in-person visit at 3 months. The ancillary study will add two telephone/videoconferencing visits at 6 and 9
months and an in-person visit at 12 months after OHCA.
For Aim 1, we will describe between-patient variability in recovery (i.e., improvement in functional, cognitive,
and HRQoL outcomes) from 3 to 12 months after OHCA, and test whether changes are associated with illness
severity scores, and critical care interventions performed during the acute care stay. Aim 2 will test whether
receipt of acute inpatient rehabilitation (vs outpatient therapy/no therapy/skilled nursing facility) within 1 month
of hospital discharge is associated with greater improvement in recovery outcomes from 3 to 12 months.
Finally, in Aim 3, we will test whether non-Hispanic Black and Hispanic/Latinx patients have less favorable
changes in recovery outcomes between 3 and 12 months and explore mechanisms for such disparities.

Public health relevance
PROJECT NARRATIVE Despite the significant public health burden associated with out-of-hospital cardiac arrest (OHCA), our understanding of the trajectory of long-term recovery and key contributors to survivorship and reaching a `new normal' after OHCA is limited. POST- ICECAP, an ancillary study to an ongoing NIH funded trial, will be the first, and certainly the largest study to describe the recovery in the most diverse group of OHCA survivors. It will comprehensively assess the relationship between the initial severity of the OHCA, critical care interventions, inpatient rehabilitation, and social determinants of health with improvement or deterioration in dependence on others for everyday activities, cognition, and quality of life in the first 12 months after survival from OHCA.